Administrative Supplement to Novel Reactions of Electrophilic Nitrogen for Preparing Bioactive Molecules

SUMMARY
Nitrogen-rich small molecules are critical to human health as they constitute the vast majority of all known
pharmaceutical agents. As the requirements for new drugs become stricter, and as the diseases that are targeted
become more complex, the chemical structures of those compounds are also becoming more complex. This is
driving the need for more efficient means to prepare ever more complex nitrogen-containing small molecules.
The parent R01 Research Project (R01GM145617-03) focuses on the development of new synthetic chemistry
methods for preparing nitrogen-rich small molecules by developing novel reactions of electrophilic nitrogen
centers. This program relies heavily on the use of High Throughput Experimentation (HTE) to accomplish these
goals, but we are currently very limited in our ability to accurately and rapidly measure solids into the 96-well
plates used in these work flows. The propose instrument will automate these steps, while providing much greater
accuracy and speed. In addition, the on-deck balance of the propose instrument will provide us with exact
quantities of added reagents in these experiments, which is critical for accuracy and is currently data we are not
able to obtain using the manual pipet methods we are currently employing. The proposed instrument will greatly
expand our ability to investigate solid reagents in HTE studies, and thus greatly expedite the proposed research
from the parent award.

Public health relevance
The treatment of human disease is highly dependent on efficient synthetic access to the nitrogen-containing small molecules that constitute the majority of pharmaceutical agents. The need for greater efficacy, safety, and selectivity in new treatments drives increases in molecular complexity, creating urgent need for new synthetic methods to prepare the required compounds. To meet this need, this proposal aims to develop new methods to construct complex, nitrogen-rich molecules by developing new reactions of highly oxidized nitrogen compounds and supporting technologies to enable their use.